The effects of APOE genotype in homeostatic microglial function in preclinical APOE mouse model

Project Summary
Alzheimer's disease (AD) is a devastating neurodegenerative condition. Aging and the 4 allele of the
APOE gene are the strongest genetic risk factor for AD. APOE is the main cholesterol transporter in the brain
that promotes neuronal growth, debris clearance, and it is mainly produced by astrocytes. Upon inflammatory
insults APOE is produced by microglia to act as an immunomodulator. Chronic inflammation exacerbates the
progression of AD pathology. Previous studies show an effect of APOE4 genotype in decreased levels of APOE
protein in the brain, increased inflammation at baseline, and simplification of dendritic spines. The studies
proposed here aim to understand APOE4-related alteration in microglial function prior AD onset. We generated
a novel human APOE knock-in mice expressing GFP under the CX3CR1 promoter to study the effects of APOE
genotype in homeostatic microglia function. So far in my thesis, I have examined the disturbances of APOE4 in
homeostatic microglial function and found that APOE4 altered microglia surveillance and response to
damage through the downregulation of chemotactic purinergic receptors. I have also studied the effects
of aging, sex, and APOE genotype in microglial function and found that aging affects microglia response to
damage, and these alterations occur earlier in APOE4 brains.
This F99/K00 proposal will encompass 2 aims presented in the following research plan. In Aim 1, I will
identify the molecular mechanism underlying microglial alteration in homeostatic function and response to
amyloid  (A). Aim 1a will examine whole transcriptome RNA-seq from APOE3 and APOE4 microglia. We will
identify genes differentially expressed in APOE3 and APOE4 microglia and investigate specific pathways
involved in altering homeostatic microglial function. Aim 1b will examine the effects of APOE genotype on
microglia's ability to recognize A prior AD onset. We will investigate microglia response to acute exposure to
A and if APOE genotype affects microglia affinity to A monomers and oligomers. Aim 1c will study APOE
protein interaction with A and its effect on phagocytosis. We will investigate APOE-A interactions and their
effect on microglia recognition of A and uptake. In Aim 2, I will continue to build skills in a post-doctoral setting
researching the mechanisms underlying microglia crosstalk with the peripheral immune system during aging and
neuronal degeneration. To achieve this, I will first identify the ideal postdoctoral lab and then obtain the
postdoctoral position. I aim to complete my postdoctoral fellowship in an institution that values innovation,
scientific rigor, training, and professional development. To obtain this fellowship, my sponsor and I are
working closely in identifying conferences and inviting speakers that will allow me to expand my network
and identify the ideal lab setting. The F99/K00 will greatly assist me in both completing my PhD and obtaining
the postdoctoral fellowship I am striving for.

Public health relevance
Narrative: Aging and APOE4 genotype are the strongest risk factor for Alzheimer's disease (AD). However, how these risk factors affect the homeostatic microglial function and responses to amyloid  (A) prior to AD pathology remains unclear. I will determine the specific mechanism by which APOE4 contributes to these dysregulations using a targeted replacement APOE mice expressing GFP in microglia by doing whole RNA-seq analysis of microglia, and studying microglia responses to A ex-vivo, potentially identifying a new AD therapeutic target.